Comparative Modeling of Precision Breast Cancer Control Across the Translational Continuum Administrative Supplement

ABSTRACT
The CISNET Breast Working Group (BWG) conducts innovative modeling research focused on new precision
oncology paradigms that are expected to re-define breast cancer control best practices. In the parent award,
we selected significant topics where modeling is suited to fill evidence gaps and facilitate clinical and policy
translation. The activities of this award have encompassed multiple lines of activity including analyses for the
US Preventive Services Task Force, publishing a cross-CISNET monograph, dedicating Rapid Response
funds to address priority areas for new investigation, and fostering the career of early-stage investigators. The
models share common inputs and provide a standard set of outcomes for benefits (e.g., distant recurrences
and deaths avoided, mortality reductions, life years and quality-adjusted life years), harms (e.g., false positives
and benign biopsies, advanced stage diagnoses, overdiagnosis and treatment impact on quality of life), and
costs. Unique components of our approach include modeling of absolute risk of disease accounting for multiple
risk factors, evaluating emerging screening modalities, addressing important comorbidities—specifically type 2
diabetes—that affect both disease risk and survival, and providing guidance regarding new precision systemic
treatments and their impact on outcomes among survivors. The specific aims of this extension are to: 1)
complete manuscripts in progress; 2) fully implement common inputs that consider important recent trends in
screening and treatment; 3) update documentation of program code and manuscript specifications; and 4)
retain essential programming staff to complete coding, finalize documentation, and facilitate future use of
breast cancer modeling resources. This scope of work would not be feasible without the availability of five
distinctive BWG models: Dana Farber (D), Georgetown-Einstein (GE), MD Anderson (M), Stanford (S), and
Wisconsin (W). This extension period will ensure that the BWG models are supported to incorporate the latest
input data and record key decisions as a foundation for future use. Retention of key programming staff will
guarantee that modeling resources will be updated, documented, and accessible for utilization in new studies.
Continuously funded for the past 25 years, the modeling teams have published >230 research papers
informing public health and trained >20 junior investigators. An experienced Coordinating Center provides the
infrastructure to support the project goals including resource sharing and model accessibility. The exceptional
environment provides unprecedented synergy and leveraging of resources to address new research questions
and support career development that would not otherwise be possible. Overall, infrastructure support for the
Breast Working Group will advance modeling research and guide breast cancer control decision making.

Public health relevance
NARRATIVE The rapid pace of discovery about breast cancer biology and screening technologies has given rise to survival gains and new precision screening and treatment approaches. The overarching goal of our application is to use collaborative modeling to inform translation of precision oncology evidence to clinical guidelines and practice by evaluating strategies to further decrease breast cancer mortality. We will use collaborative breast cancer simulation modeling as a virtual laboratory to inform patient and clinician decision-making by evaluating the impacts of evolving precision cancer control paradigms.